Childhood-onset hypomyelinating leukodystrophy and the multi-tRNA synthetase complex

Project Summary/Abstract
Child-onset hypomyelinating leukodystrophy (HLD) is a genetically heterogeneous group of neurodegenerative
diseases characterized by reduced cerebral myelin formation. Clinical features include cognitive as well as
motor impairment appearing in childhood. There are no curative treatments. Our collaborator, Dr. Grace Yoon,
evaluated two siblings presenting with severe neurological deficit and a shared phenotype consisting of global
developmental delay and intellectual disability, prenatal onset undergrowth and microcephaly, rotatory
nystagmus, ataxia and progressive gait disturbance/spasticity, and hypomyelination on brain MRI. Whole
exome sequencing revealed homozygosity of a c.4444C>A mutation in the EPRS1 gene. The mutation is in
the coding sequence (cds) of the gene causing a Pro-to-Thr point mutation at aa position 1482. The EPRS1
gene encodes the bifunctional, glutamyl-prolyl tRNA synthetase (EPRS1) that resides in the cytoplasmic multi-
tRNA synthetase complex (MSC). The P1482T mutation is located near the C-terminus of the protein in a
region of the Pro synthetase outside the catalytic or anti-codon recognition domains. The specific activity of
recombinant P1482T mutant EPRS1 is indistinguishable from wild-type. In contrast, EPRS1 protein expression
in immortalized lymphoblastoid cell lines (LCL) from affected siblings is about 20% of that in unaffected
controls. EPRS1 mRNA levels are identical in siblings and controls indicating post-transcriptional regulation.
Our preliminary studies show a dual mechanism determining diminished EPRS1 level in affected LCLs,
namely, decreased nuclear export of mutant mRNA, followed by decreased cytoplasmic translation. We show
that decreased EPRS1 expression causes release of other MSC constituents. Remarkably, suppression of
several other MSC components causally implicated in HLD also induce MSC constituent release, suggesting a
common etiology of an entire class of HLDs. We hypothesize that inefficient nuclear export and translation of
c.4444C>A EPRS1 mRNA reduces MSC-bound EPRS1, causing release of MSC constituents and driving the
HLD phenotype. Likewise, defects in genes encoding other MSC constituents share a common pathway and
etiology of HLD. We will test this hypothesis by pursuing these Specific Aims: In Aim 1 we will elucidate
molecular mechanisms underlying reduced expression of EPRS1P1482T variant, focusing on the role of m6A
methylation. Aim 2 determines the HLD-related phenotype of our newly generated, genetically-modified
Eprs1P1482T mice. In Aim 3 we will investigate effect of deficiency of MSC constituents on MSC integrity and
adverse consequences in myelinating oligodendrocytes. A CNS-specific transcriptomic analysis will be done by
single-nucleus RNA-sequencing. Completion of these studies will elucidate a unique mechanism of gene
dysregulation that induces HLD, and will provide a unique mouse model of HLD that will permit detailed in vivo
analysis of the cellular defects in HLD. Importantly, these results suggest the possibility of specific, RNA-based
therapeutic intervention to rescue translation of the variant EPRS1 mRNA and rescue the neurologic defect.

Public health relevance
Project Narrative Hypomyelinating leukodystrophy (HLD) is a genetically heterogeneous group of neurodegenerative diseases characterized by reduced cerebral myelin formation, as well as cognitive and motor impairment appearing in childhood. In a pair of siblings with HLD, we have discovered a Pro-to-Thr mutation in the coding sequence of the EPRS1 gene that encodes a bifunctional tRNA synthetase (glutamyl-prolyl tRNA synthetase) and leads to its reduced expression without altering its activity. Here, we will investigate in detail the mechanism of reduced expression of EPRS1 in cells and in a novel mouse model of HLD generated by the CRISPR/Cas9 system.